Social Modulation of Transitions in Diabetes: Synthesizing Data Sets and Biomeasure Assays

Project Summary
The epidemic increase in the prevalence of diabetes and obesity is a public health crisis. Addressing this
epidemic requires understanding the variation within the population in how people transition among non-
diabetic, pre-diabetic, and diabetic states, as well as their morbidity and mortality. A comprehensive study of all
transitions and outcomes in a nationally-representative sample of US older adults is critical to accurately
forecast future prevalence and demand for health care. Equally important is identifying novel approaches to
reduce diabetes risk, its complications and mortality. While behavioral interventions are beneficial, we have
early evidence that people’s social interactions may also independently reduce diabetes risk and progression.
Our central hypothesis is that a significant portion of individual variation in diabetic trajectories is
associated with different social environments. We will test our hypotheses by (1) combining two high-
quality, national datasets, each with unique strengths, creating a synthesized data set more
comprehensive than either alone and (2) assaying a broad panel of biomeasures (including A1C). The
National Social Life, Health, and Aging Project (NSHAP) has collected longitudinal data at three waves (2005,
2010 and 2015 (2015 biomeasure to be assayed here), health data, medication usage, as well as the most
comprehensive assessment of social relationships and intimate partners of any national survey of older adults.
The Health and Retirement Study (HRS) has also collected longitudinal A1C and social data from a larger
sample of older adults bi-yearly since 2006. The proposed analyses combine these datasets to increase the
precision of our estimates, while leveraging NSHAP’s unique social and biological data. The tools we develop
for combining and analyzing these datasets are applicable to other chronic diseases and conditions of aging
and will be made freely available to the research community, along with complete biomeasure data, providing
an invaluable public resource for studying a wide range of health issues. For Aim 1, we will estimate the
transition rates among non-diabetic, pre-diabetic, and diabetic states in the U.S. population of older adults by
obesity, health status, and demographic subgroups. For Aim 2, we will test the hypothesis that social factors
such as large social networks, positive social and intimate relationships, social support, social participation,
social stress-buffering and low levels of isolation and loneliness are associated with a lower likelihood of
diabetes progression and even reversals. For Aim 3, we will test whether differences in the rate of diabetic
transitions are mediated through specific physiological (inflammation, stress biology, sex steroids) and health
behavior mechanisms (activity and sleep). Understanding the mechanisms by which social factors affect
diabetes risk may help 1) better target specific types of social interventions to the social context of individuals,
2) demonstrate how social interventions need to vary by diabetic transition, and 3) identify key members of a
social network that would be most effectively targeted as part of a social intervention.

Public health relevance
Project Narrative Addressing the diabetes and obesity epidemic effectively requires understanding the different ways that diabetes develops, progresses, and gives rise to complications and mortality. People’s social interactions may reduce diabetes risk and progression. This proposal will generate national estimates of diabetes risk, characterize the social modulation of this risk, and explore the biological underpinnings of this social modulation.